PREPROCEDURE TELEPHONE EDUCATION AND ASSESMENT IN PEDIATRIC SEDATION

The purpose of this study is to determine whether patient satisfaction is increased and number of cancellations is decreased when Pediatric Sedation Clinic patients are contacted by nursing staff prior to their scheduled visit compared to the present protocol (no pre-visit phone call). Study Hypotheses: Pediatric patients/families who are contacted at home prior to sedation for a procedure, as compared to those families who are not contacted, will: (1) have fewer cancellations at the time of the clinic visit; (2) have fewer "no shows"; (3) express greater satisfaction with the pre-visit information they received; (4) perceive themselves as having participated more fully in care; (5) express greater overall satisfaction with the preparation and education they received; and (6) require less nursing time for education in clinic. Specific Aims: (1) to determine what the frequency of cancellations is in control and study groups; (2) to determine what the frequency of "no shows" is in control and study groups; (3) to compare parental satisfaction in control and study groups with respect to (a) the information they received in preparation for clinic visit, (b) their level of participation in care, and (c) their overall satisfaction with preparation for clinic visit; and (4) to determine if there are differences between control and study groups in nursing time necessary to prepare patients/families for sedation.